Development of a metabolomics enabled AI/ML platform for discovery of new treatments to enhance drug sensitivity in cancer

Project Summary
Coupling high-throughput omics technologies with machine learning and the phenotypic-based drug discovery
paradigm allows for data-driven drug discovery (D4). D4 has the advantage of being unbiased, like phenotypic-
based drug discovery, but the comprehensive measurements of 100s to 100,000s of biological features also
enables characterizing drug perturbations and disease signatures to gain mechanistic insights. The predominant
data type for D4 has been transcriptomics and more recently image-based assays. Other biomolecules (i.e.,
proteins and metabolites) are considered closer to the phenotype, however technical challenges in data
generation and analysis, as well as the lack of standardized data analysis pipelines have limited the systematic
use of these data types. Sinopia Bioscience and Omix Technologies have combined their strengths in systems
biology data analysis, AI/ML, and LC-MS/MS based metabolomics to develop a unique metabolomics-based
platform that has allowed for systematic metabolic characterization of a chemical library consisting of ~3,300
small molecules covering more than 1,000 drug targets. Our preliminary results demonstrate that metabolomics
is more sensitive, reproducible, and predictive of the mechanism of action of these small molecules than
transcriptomics. Further, we found that using metabolomics data we could predict cell line specific toxicity of
cancer drugs in viability assays. Importantly, we found we could derive metabolic signatures of sensitivity and
resistance and use these to identify secondary compounds that can enhance sensitivity to cancer drugs. In this
Phase I proposal, we will expand on these findings and develop novel algorithms to better understand how
baseline metabolic states of cancers affect their sensitivity to cancer drugs. As a development test case we will
focus on sensitivity of breast cancer cell lines to docetaxel and tucatinib. First, we will perform high throughput
metabolomics and analysis of 100 cancer cell lines to characterize metabolism both in a baseline state and after
administration of docetaxel and tucatinib. Second, we will develop novel computational algorithms for predicting
the ability of compounds to sensitize cancer cells to cancer drugs. Finally, we will experimentally validate novel
compound combinations and generate metabolomics data to further improve our algorithms. Success of this
Phase I proposal will lead to validated metabolomics-based methods for identifying underlying metabolic
phenotypes predictive of drug sensitivity, which will then be leveraged to predict the effects of compound
combinations. This allows us to further expand Sinopia’s platform’s capabilities and its application to oncology
applications through partnerships with biotech/pharma and/or fundraising through outside investors. In addition,
it would lead to novel use of targets and compounds to enhance the sensitivity to existing cancer treatments that
we can internally develop. Phase II will focus on further development of the platform, expanding our
metabolomics-based library, and advancing promising synergistic combinations into preclinical models.

Public health relevance
Project Narrative Omics technologies and machine learning have the potential to accelerate drug discovery. However, data types that are closest to the phenotype, such as metabolomics, have not been as systematically utilized as other data types. Sinopia Bioscience and Omix Technologies have developed methods for high-throughput data generation and analysis and have built a unique platform for metabolomics-based data-driven drug discovery. This proposal will further develop the platform for application in cancer, an area in which altered metabolism plays a critical role.